Understanding Cell-type Vulnerability and Oxidative Stress Pathology in Parkinson's Disease Using Isogenic Human Dopaminergic Neurons

Project Summary: Understanding cell-type vulnerability and manipulating oxidative stress pathology
in Parkinson’s Disease using isogenic human dopaminergic neurons
About one million Americans live with Parkinson’s Disease (PD) which is characterized by progressive loss of
subpopulations of nigral midbrain dopaminergic neurons (DNs), leading to motor impairment and other
debilitating conditions. Familial PD genes show broad expression in the brain and neurodegeneration in PD can
be widespread; however, it is unclear why nigral DNs show such exquisite vulnerability compared to other cell
types, including other DN populations. Post-mortem studies suggest that oxidative stress (OS) contributes to
familial and sporadic PD. Reactive oxygen species (ROS) are important signaling molecules but high levels of
intracellular ROS will damage DNA, lipids and proteins. High energy needs and dopamine metabolism may
explain increased ROS, OS and the unique vulnerability of nigral DNs but human-relevant model systems are
required to rigorously test this hypothesis. There is an urgent need to develop experimental systems to better
understand nigral DN vulnerability, identify novel disease-relevant signaling mechanisms, and improve molecular
subtyping and patient stratification. In this supplement we propose to use a recent model that we have developed
and apply it to dissect pathological cell-type-specific mechanisms. We have recently developed a 3D culture
model integrating induced pluripotent stem cells (iPSCs) derived individual cell types (neurons, astrocytes,
oligodendrocytes, endothelial cells to create brain tissue chips. This approach allows us to integrate cells with
different genetic backgrounds. To this end, we aim to investigate the cell type specific effects of familial PD
genes PARKIN and DJ1 to better understand the role each brain cell type plays to contribute to PD pathology.
Specifically, we aim to determine the impact of PARKIN variants in each cell type on oxidative stress in human
brain tissue by creating brain tissue chips with PARKIN loss of function mutations in different cell types. We will
monitor oxidative stress in the dopaminergic neurons. Additionally, we aim to determine the impact of DJ1 risk
variants in each cell type on proteostasis and dopaminergic neuron survival by introducing different cell types
with DJ1 loss of function variants. We will measure proteolytic activity and neuronal death as a result of DJ1 loss
of function in different cell types. Applying the 3D tissue chip system to PD will allow us to identify the role of
each cell type in contributing to PD pathology.

Public health relevance
Project Narrative: Understanding cell-type vulnerability and manipulating oxidative stress pathology in Parkinson’s Disease using isogenic human dopaminergic neurons This research proposal will inform public health decisions, as our findings will transform how clinicians and scientists think about neurodegeneration in Parkinson’s Disease. Understanding factors that render cells vulnerable to degeneration and the common and distinct mechanisms of molecular dysregulation underlying the disease states, particularly among inherited or familial subtypes, will increase the accuracy and precision to predict risk, improve diagnosis and establish a new framework for innovative therapeutic strategies in line with the mission of the NIH to improve the human condition. Additionally, this supplement will provide Dr. Schwarz with the necessary training to learn stem cell techniques and expand upon her microscopy and image analysis skills with the end goal of preparing her for an independent research career.